Mechanism and function of small RNAs in development and gene silencing in the germline

PROJECT SUMMARY
Despite their diminutive length, 20-30-nucleotide-long small RNAs affect nearly all developmental and disease
processes, from fertility in flies to cancer in humans. Small RNA associate with Argonaute proteins to direct
sequence-specific degradation or translational repression of matching mRNAs in a process called RNA
interference (RNAi). Small RNAs can also function in an alternative mode to promote gene expression. Within
the germline of the tiny nematode worm, Caenorhabditis elegans, two broad classes of small RNAs – piwi-
interacting RNAs (piRNAs) and small interfering RNAs (siRNAs) – interact with nearly all genes, silencing
some and promoting the expression of others. Remarkably, some piRNAs and siRNAs are transmitted from
one generation to the next, providing a heritable mechanism for regulating gene expression without changes to
the underlying DNA. In C. elegans, piRNAs and siRNAs are required for optimal fertility and germline
immortality. We and others identified a role for maternally-derived piRNAs and siRNAs in protecting essential
genes from silencing. We also showed that these small RNAs have a role in establishing proper gene
expression in the embryo that is crucial throughout development, although the mechanism underlying this
phenomenon requires further study. To identify the roles of piRNAs and siRNAs in ensuring proper gene
expression from one generation to the next, we will address two related questions: 1) How do piRNAs and
siRNAs regulate gene expression to promote fertility and germline immortality? and 2) What are the molecular
roles of maternally deposited piRNAs and siRNAs? A second area of my research centers on gene regulatory
mechanisms involving a third class of small RNAs, called microRNAs (miRNAs). We recently uncovered a
distinct branch of the miRNA pathway required for proper developmental timing and optimal fertility in the
germline. How this pathway regulates gene expression is an important area of future research. This relates to
the third question we will address: 3) How do miRNAs regulate developmental timing in the germline? miRNAs
are processed from a limited number of transcripts that form hairpin-like secondary structures. The hairpin itself
is not sufficient to mark a transcript for processing, and in many species, including humans, primary transcripts
contain additional sequence elements that promote miRNA formation. Not all miRNA transcripts contain these
elements and in some animals, including C. elegans, they are completely lacking. We developed a sensor that
reports on miRNA transcript recognition. Using the sensor, we will address a fourth question: 4) How are
miRNA transcripts distinguished from other RNAs in C. elegans? The ease in which genetics, genome editing,
and genomics assays can be done in C. elegans makes it an ideal system to address these four questions.
The mechanism of miRNA formation and the molecular roles of miRNAs, piRNAs, and siRNAs are highly
conserved in animals. The knowledge gained through this study will have important implications in our
understanding of the counterparts in humans and how their dysfunction contributes to sterility and disease.

Public health relevance
PROJECT NARRATIVE Nearly all cellular processes are influenced by small RNAs and their dysregulation has been implicated in fertility defects and disease. This study uses genetics and genomics to advance our understanding of how small RNAs control gene expression in the germline. The results will uncover new roles for small RNAs and mechanisms underlying small RNA function that preserve fertility and health from one generation to the next.